mRNA assembly in Drosophila germ granules

mRNA ASSEMBLY IN DROSOPHILA GERM GRANULES
Development of every species relies critically on spatially organized messenger RNAs (mRNAs). Indeed, even a
single asymmetrically distributed mRNA can specify the morphology of cells, the body plan of a developing
organism and cell lineages across metazoans. RNA binding proteins (RBPs) typically organize mRNAs and
recruit them to subcellular structures. However, mRNAs can also self-organize into multi-mRNA assemblies
independently of other cellular components. mRNA assemblies are found in healthy cells in different species
and are often associated with RNA granules, membraneless ribonucleoprotein (RNP) particles that regulate
translation and stability of mRNAs. mRNA assemblies are also a hallmark of pathogenesis in human repeat
expansion disorders such as myotonic dystrophy 1 (MD1), amyotrophic lateral sclerosis (ALS) and
spinocerebellar ataxia (SCA). These findings indicate that mRNA assembly is an inherent property of an mRNA
that could be biologically relevant. However, the exact mechanism and potential biological functions of mRNA
assembly is unclear. mRNAs have been shown to self-assemble by phase separation, a process akin to oil-and-
water de-mixing. Here, RNA:RNA interactions, which promote intermolecular (trans) base-pairing and
secondary (cis) RNA structures have been implicated in driving mRNA assembly. In addition, in vitro data
suggest that RNA helicases, which are core constituents of RNA granules are thought to dissolve RNA:RNA
interactions in granules. In light of these findings, several critical questions arise. How do mRNAs self-
assemble in granules designed to prevent RNA:RNA interactions? What is the role of mRNA assemblies in
RNA granules? And what is the role of trans and cis RNA:RNA interactions and RNA helicases in the formation
and function of mRNA assemblies and RNA granules? mRNA assemblies tend to form as small clusters that are
acutely sensitive to the concentration and the environment in which they form. Thus, the central challenge
in studying mRNA assembly is that methods must be employed that enable examination of this process in
vivo and with high resolution and sensitivity. To achieve this, my lab will use genetic and quantitative,
super-resolution imaging approaches to analyze mRNA assembly in intact cells and within their
natural cellular context. Our goal is to understand how organisms form and harness mRNA assemblies to
promote development and to uncover new insight into how misregulation of mRNA assembly could contribute
to human diseases, such as MD1, ALS and SCA.

Public health relevance
Public health relevance Messenger RNAs (mRNAs) transfer genetic information from the nucleus to the cytoplasm where they are translated. Establishment of the fly and frog lineages that provide continuity of the species and mammalian synaptic activity rely critically on mRNA localization. However, in humans, mislocalized mRNAs cause muscle disorders such as myotonic dystrophy 1 and have been linked to neurodegeneration, including amyotrophic lateral sclerosis. Our findings in this study will elucidate how organisms harness spatially organized mRNAs to promote development. Importantly, this knowledge will also enable fundamental understanding of how misregulation of mRNA localization could contribute to diseases such as MD1, ALS, and SCA.